Physical Activity, Sedentary Behavior, and Venous Thromboembolism Risk

Abstract:
Venous thromboembolism (VTE) is the third most common cardiovascular disease in the United States.
Venous stasis, which can occur during prolonged periods of inactivity, is a known risk factor for VTE; however,
the relationship between physical activity and VTE is inconsistent and guidance regarding physical activity after
a VTE is lacking. The overarching goal of the proposed scientific aims is to further our understanding of the
associations of physical activity and sedentary behavior in relation to: (1) incident VTE risk, (2) short-term VTE
risk following physical activity, (3) long-term prognosis following an incident VTE, and (4) hemostatic factor
levels, which are associated with thrombotic event risk. This study will leverage existing data from the robust
Women’s Health Initiative and the Nurses’ Health Studies I and II cohorts in addition to newly collecting data in
the setting of a case-crossover study. Innovative aspects of the proposed work include the evaluation of
accelerometer-measured physical activity and sedentary behavior in relation to VTE risk, the evaluation of VTE
risk following physical activity using case-crossover methodology, the evaluation of physical activity and
sedentary behavior with long-term prognosis among VTE survivors, and the evaluation of usual physical
activity in relation to hemostatic parameter measures. Not only are the proposed scientific aims of

Public health relevance
Narrative: It is not well understood whether physical activity and sedentary behavior are associated with the risk of venous thromboembolism (VTE) (blood clots), even though VTE is the third most common cardiovascular disease in the United States. This work proposes to improve our understanding of whether these behaviors are associated with the risk of a first VTE, whether they may be a trigger of a VTE, whether they are associated with mortality after a VTE, and whether they are associated with hemostatic biomarker levels, which will lead to an improved understanding of this association of public health relevance.